Chromatin architecture as a regulator of dendritic cell function

PROJECT ABSTRACT
Dendritic cells (DCs) are immune sentinel cells that can be activated by innate stimuli to orchestrate adaptive
immune responses. Conventional DCs (cDCs) efficiently present and cross-present antigens to prime T cell
responses, whereas plasmacytoid DCs (pDCs) rapidly produce type I interferon (IFN-α/β, IFN-I) and other
cytokines in response to pathogen-derived nucleic acids. Recent studies revealed an intricate topological
organization of the genome into topologically associated domains (TADs) established through cohesin-
mediated loop extrusion and demarcated by binding sites of transcription factor CTCF. CTCF/cohesin-
mediated chromatin architecture is thought to control cell type-specific gene expression programs, thereby
facilitating cell differentiation and function. However, the topological chromatin landscapes of DCs and their
role in DC differentiation and function are poorly understood. The overall goal of the project is to characterize
the chromatin architecture in DCs and elucidate the chromatin-level control of DC function. In Aim 1, we will
examine the role of CTCF/cohesin-mediated regulation in the differentiation of DC subsets. In Aim 2, we will
analyze the role of cohesin in DC function, including cytokine responses and antigen presentation. In Aim 3,
we will analyze the architecture of the locus encoding IFN-I genes, and the role of chromatin in the control of
interferon production in DCs. Collectively, these results would provide novel insights into the role and
mechanism of chromosomal organization in the regulation of DC differentiation and function.

Public health relevance
PROJECT NARRATIVE Innate sensing of pathogens by dendritic cells (DCs) and subsequent DC-mediated priming of immune responses is critical to successful control of infections, yet may be subverted in autoimmune diseases and cancer. The proposed studies would provide novel molecular insights into the control of DC functions, facilitating future therapeutic approaches to above-mentioned diseases.